DRUG DISCOVERY BY DIRECTED EVOLUTION IN MAMMALIAN CELLS

Project Summary
Directed evolution, which adopts principles of natural evolution to the laboratory, is singular in its impact on
molecular engineering. As one example, it is responsible for the generation of the majority of approved
therapeutic antibodies and those still in clinical development. Despite its progress, a valuable therapeutic niche
remains outside its scope: the mammalian cell. While in vitro systems, phage, bacteria, and yeast have lent
themselves to laboratory manipulation, mammalian cells have proven less tractable. Consequently, the power
of evolution remains inaccessible to drug development pipelines that seek to modulate mammalian cell
signaling. Further, many directed evolution campaigns result in biomolecules that fail in critical ways when
transplanted to human cells. To address these limitations and advance methods in drug discovery, I will
explore and mine viral diversity to create a novel system for molecular evolution in mammalian cells. Next,
focusing on the 5-HT2A serotonin receptor, I will create extracellular nanobodies to template a drug discovery
campaign via structural determination and in silico docking. The insights gained by these studies will be
applied toward the directed evolution of state-specific nanobodies against dark GPCRs. This work will result in
a general method for directed evolution in mammalian cells, chemical matter against HTR2A, and new paths
forward for the deorphanization of GPCRs.

Public health relevance
Project Narrative Drug discovery remains a cost-, labor-, and time- intensive endeavor with a high failure rate. The proposed work will use genetic diversity found in nature to create a new system for molecular evolution in mammalian cells and deploy it against a high-value drug target. In doing so it will transform our current drug discovery pipeline and create new paths forward to treat human disease.